Scalable spatiotemporal-omics platform

PROJECT SUMMARY/ABSTRACT
Accurately predicting the clinical efficacy of drug candidates during pre-clinical drug discovery has the power to
revolutionize the biopharmaceutical industry. To this end, “profiling” techniques have gained rapid adoption in
the drug discovery processes because these techniques can assess a broad range of features – such as gene
expression or spatial features – offering a holistic understanding of a drug’s potential impact. The collected profile
data can be utilized to identify and validate new drug targets, elucidate mechanisms of action, pinpoint promising
drug candidates, and reposition drugs, ultimately providing multi-faceted benefits during pre-clinical drug
discovery. However, a critical limitation of current profiling techniques is that they fail to assess how drugs affect
spatiotemporal properties by altering the genomic, epigenomic, transcriptomic, and proteomic underpinnings of
cells. This is a critical limitation because many disease abnormalities and drugs’ therapeutic effects manifest via
changing the spatiotemporal properties of cells. Therefore, linking these cellular spatiotemporal properties
to underlying omics data can provide a powerful insight into drug mechanism and function. While spatial
omics platforms do exist, their prohibitive costs and limited utility in live cell cultures make them unsuitable for
pre-clinical drug discovery. To address this issue, Imagen Bioworks is developing an innovative spatiotemporal-
omics workflow suitable for pre-clinical drug discovery. This workflow, SPOTlight-omics, is a cost-effective
technique that can isolate interesting spatiotemporal phenotypes from live cell cultures. We plan to use the
SPOTlight platform to isolate a subpopulation of cells showing disease-relevant spatiotemporal properties after
drug exposure and subject the isolated cells to subsequent omics assays. Two critical hurdles must be overcome
before SPOTlight-omics is ready to be commercialized: (Aim 1) Achieving faster optical tagging and enabling
cell sorting of multiple phenotypic subgroups. Achieving Aim 1 will provide significant timesaving, increase in cell
isolation yield, and enable greater types of downstream omics assays. (Aim 2) Demonstrating the feasibility and
the utility of using SPOTlight-omics to profile the effects of drugs on spatiotemporal properties. Overall, our
proposal leverages recent advancements in computer vision, spatial/temporal omics, multi-omics, and drug
profiling. Successful completion of this proposal will lead to a new drug profiling technique that our biopharma
customers can utilize to gain additional insights into the function of drugs during pre-clinical drug discovery.

Public health relevance
PROJECT NARRATIVE Using multi-omics to unravel how diseases and therapeutics affect the spatiotemporal properties of the cells has the power to discover new drug targets, elucidate mechanisms of action, and pinpoint promising drug candidates. However, current omics methods fall short when it comes to cost-effectively generating spatiotemporal omics data for drug profiling applications. Imagen Bioworks Inc. is developing a versatile and scalable spatiotemporal omics workflow that can be used for drug profiling during pre-clinical drug discovery.